Improving Food Protection Through EHS-Net Research

DESCRIPTION (provided by applicant): Project Summary/Abstract The Rhode Island Department of Health (HEALTH), as part of the Environmental Health Specialist Network (EHS-Net) Grant, will conduct research as to root causes and how to most effectively reduce foodborne illnesses, disabilities and death. Reducing miscarriages and deaths due to Listeriosis associated with consuming luncheon meats sliced at retail is a priority for Year One research. Environmental swabs and inspections will be used to evaluate design and construction problems associated with slicers that may be contributing to Listeriosis and Salmonellosis. Findings will be used to inform NSF International in the revision of international design standards for slicers. Research may also result in the recall of unsafe slicers that pose a serious food safety hazard. Subsequent research will focus on root causes for the transmission of Salmonellosis, Norovirus, and other EHS-Net identified priority illnesses. Barriers and facilitators to eliminating foodborne illness risk factors will be identified. Best practices to eliminate foodborne illness risk factors will be identified along with how best to improve the effectiveness of inspections to protect public health. HEALTH seeks to work with EHS-Net to collaborate in identifying the most effective means for reducing foodborne illnesses and deaths. Participating in this statewide effort will be three segments of the HEALTH: the Office of Food Protection, the Office of Communicable Diseases, and the RI Department of Health Laboratories, as well as the Rhode Island Food Safety Task Force, the University of Rhode Island and Johnson and Wales University. HEALTH will collaborate with EHS-Net in the analysis of data and findings from all EHS-Net research projects, and in the development and dissemination of scientific publications and health advocacy initiatives for the environmental public health community through scientific journals, presentations at professional meetings, and other effective means.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative As part of this EHS-Net grant, the Rhode Island Department of Health (HEALTH) will determine why Listeriosis is associated with consuming luncheon meat sliced at retail in order to prevent miscarriages, and deaths among the elderly and other high-risk groups. Strategies to reduce Listeriosis, Salmonellosis, Norovirus and other EHS-Net targeted illnesses will also be developed and disseminated through scientific journals, presentation at national conferences and other effective means. __SpecificAimsTextDelimiter__ 2. Specific Aims In the previous five years of this grant, Rhode Island conducted research on E. coli O157:H7 and was instrumental in changing the FDA Model Food Code to prohibit the sale of undercooked ground meat sold through children's menus to reduce childhood illness, disability, and death due to this Healthy People 2010 targeted pathogen. EHS-Net and FDA research has shown an association between foodborne outbreaks and the presence of foodborne illness risk factors and the lack of a manager certified in food safety. Rhode Island has also introduced a proposed change to the FDA Model Food Code to require a manager certified in food safety in most food establishments. Rhode Island will continue to target Healthy People 2010 Objective 10.1 "Reduce infections caused by key foodborne pathogens." High priority will be given to reducing illness and deaths due to miscarriages and deaths of the elderly and other high-risk individuals due to Listeriosis associated with consuming luncheon meat obtained from retail food establishments. Rhode Island will also target reducing illness due to Salmonellosis and Norovirus during this research. Toward this end, HEALTH seeks to continue it's collaboration with EHS-Net in research that identifies food safety issues, develops appropriate research projects to address the issues, proposes interventions and/or best practices based on these projects, and disseminates findings. In alignment with EHS-Net research objectives, HEALTH seeks to accomplish the following Specific Aims: Aim 1: EHS-Net Foodborne Disease Outbreak Research The HEALTH Office of Food Protection (OFP), Office of Communicable Diseases (OCD), and RI State Divisions of Laboratories will collaborate to conduct EHS-Net environmental assessments, and other activities, related to suspected foodborne outbreaks in retail foodservice, grocery stores and domestic food manufacturing/processing plants. " For each grant year, HEALTH will account for, collect data and specimens, and report to EHSNIS & NORS, 100% of suspected foodborne illness outbreak events within Rhode Island. Aim 2: EHS-Net Special Studies Research HEALTH will conduct EHS-Net Special Studies, and other activities, to identify and understand environmental factors associated with food safety practices & policies, foodborne illness outbreak events, and food safety hazard management systems. " HEALTH will collect and submit 100% of data and specimens for all Special Studies agreed-to each year, and will collaborate with EHS-Net on all related activities (including protocol development workgroups, Human Subject Research IRB approval, study pilot testing, data analysis, active participation in steering committee meetings and annual planning meetings, etc.), and other related work (per annual EHS-Net Performance Criteria & Continuation Application Plan). Aim 3. Evaluating and Improving Environmental Health Service Programs As may be required by CDC, HEALTH looks forward to full participation in the National Environmental Health Performance Standards Pilot Program by completing an assessment of the HEALTH / OFP program using the Environmental Health Performance Standards developed by CDC as part of the 2011 voluntary public health department accreditation process. " Once the standards are developed, HEALTH will conduct interagency collaborative projects to evaluate the food safety program and intervention activities, and develop a plan to take appropriate actions to address issues, integrate continuous improvement methods and measures, and report findings to EHS-Net (per annual EHS-Net Performance Criteria & Continuation Application Plan). " HEALTH plans build on this activity in later grant years by preparing for accreditation under the National Public Health Accreditation program. Aim 4. Active Dissemination of EHS-Net Research HEALTH will collaborate with EHS-Net in the analysis of data and findings from all EHS-Net research projects, and in the development and dissemination of scientific publications and health advocacy initiatives for the environmental public health community (per annual EHS-Net Performance Criteria & Continuation Application Plan). " HEALTH will develop articles, newsletters, handouts, and presentations based on EHS-Net research results (e.g. Outbreak or Special Studies) for dissemination to members of the national, regional & statewide public health community and foodservice industry. " HEALTH will assist EHS-Net with environmental public health advocacy, as may be required (e.g. FDA Model Food Code revisions, EHS-Net related work with national food industry associations).